HWWTP

Program Summary/Abstract (HWWTP)
Project Title: IBT Hazardous Materials Worker Health and Safety Training
(HWWTP)
Under the HWWTP, the IBT Consortium will build institutional competency and create a sustainable worker
health and safety training program. Hazardous waste remediation workers, construction workers at hazardous
waste sites, and transportation and warehouse workers encounter myriad occupational hazards such as:
working at heights, in excavations, heavy lifting, falling objects, electrical hazards, and exposures to chemicals.
Consequently, it is critically important for these workers to receive training to ensure that they are able to
identify occupational hazards and able to take actions to protect themselves, their coworkers, and the
surrounding environment.
The targeted population for the HWWTP is workers who are engaged in hazardous waste remediation,
hazardous materials transportation, warehousing, solid waste and recycling, airline, rail, and emergency
response.
The IBT Consortium proposes to recruit workers within the targeted industry sectors through relationships and
partnerships with employers, unions, community-based organizations, and 11 regional training centers to
conduct 1,640 classes for 19,920 workers during the 5-year funding period. The IBT Consortium is in a unique
position to deliver relevant, high quality health and safety training to workers due to our infrastructure, mobile
training capability, staffing, extensive experience, and expertise.
The long-term objectives and specific aims of the IBT Consortium are to increase worker, community, and
environmental safety and resilience by training workers to respond to accidental releases of hazardous
materials, work safely on hazardous waste remediation projects, and safely transport hazardous materials via
truck, rail, and air.

Public health relevance
Project Narrative (Overall) The IBT Consortium represents and has ready access to tens of thousands of workers throughout the U.S. who remediate hazardous waste sites, transport hazardous wastes, handle, package, transport and warehouse hazardous materials, and respond to hazardous materials releases. The IBT Consortium has over 1.3-million- member workforce that connects to employers, affiliates, communities, and individuals The IBT Consortium is staffed by a team of experienced worker health and safety training experts who specialize in industrial hygiene, curriculum development, adult education techniques, information technology, website and media development, data analysis, and craft-experienced worker-trainers. Through the IBT Consortium, the program has access to various stakeholders including: environmental groups, public health workers, railroad workers, and tribal entities, such as the Tribal Employment Rights Office (TERO) of the Confederated Tribes of the Umatilla Indian Reservation in the Pacific Northwest region. The combination of access to worker populations and institutional capacities enables the IBT Consortium to deliver high quality model training that complies with the NIEHS Minimum Criteria, applicable standards and regulations as promulgated by the Environmental Protection Agency, Occupational Safety and Health Administration, and the Department of Homeland Security.